Low-dose contrast enhanced fast pediatric brain MRI

Project Summary: Brain MRIs are widely used in children for diagnosis and treatment monitoring. A typical
exam comprises multiple sequences with different contrast preparations, and often requires 20+ minutes to
complete. Potential motion during such lengthy acquisitions necessitates sedation or anesthesia. However,
repeated sedation or anesthesia in children increase the risk of long-term detrimental effects on cognitive
development. 40% of these pediatric scans also require gadolinium (Gd) based contrast agent (GBCA)
administration. It has been recently shown that Gd is retained in the brain and body, which may be particularly
harmful to children since their developing brains are more susceptible to heavy metal exposure, and free
lanthanides are known to be neurotoxic. Pediatric brain exams are excessively long because of inefficient use
of parallel imaging technology that only provides R=2–3-fold acceleration. Acceleration in two dimensions,
including the slice/partition axis, through controlled aliasing in parallel imaging (CAIPI) has enabled R=4–6-fold
speed-up, and has become popular in functional/diffusion imaging using simultaneous multislice (SMS)
encoding. Unfortunately, adoption of SMS in clinical sequences has been extremely slow. Acceleration via
Compressed Sensing (CS) is a promising solution, but its availability as a product solution is variable among
MR vendors, and it often comes at the cost of low-contrast image features. Deep learning (DL) has emerged
as a powerful reconstruction and image enhancement tool. Vendors’ DL solutions include denoising and super-
resolution enhancement, but these are limited to the newest software versions and host computers with GPUs.
While promising a better trade-off between image quality and scan time, they are currently implemented for a
small number of sequences on different vendors, and are therefore constrained by poor availability and
scalability. Thus, current clinical technologies have been hampered by limited availability and faster has often
meant suboptimal quality. Lastly, no vendor has DL-based solutions for Gd dose reduction for either adults or
children. Given the need for repeated injections of sedatives and GBCA in children who are scanned
periodically for treatment monitoring, there is an unmet need in imaging technology that makes these young
populations vulnerable to severe and long-term health risks. We propose data acquisition, reconstruction and
contrast enhancement strategies to address this unmet need. In Aim1, we will develop a rapid, comprehensive
brain exam by combining our advanced controlled aliasing strategy, wave-CAIPI, and extend this to SMS
encoding for rapid FLAIR/TSE imaging. Combining this with DL super-resolution reconstruction will enable
R=9-fold acceleration with high fidelity to create a 6-min protocol. In Aim2, we will develop and validate a DL-
based contrast enhancement algorithm to synthesize full dose images from 5× reduced Gd dose in pediatric
exams using our rapid protocol from Aim1. To that end, our novel technologies would speed up the clinical MR
exams and minimize both the amount of sedation and the injected contrast agents dose in children.

Public health relevance
Project Narrative Obtaining high quality pediatric brain MRIs with gadolinium (Gd) injection takes long (20+ minutes) time, and often necessitates sedation or anesthesia, which hinders normal brain development and poses increased risk for cognitive and behavioral problems later in life. We propose synergistic data acquisition, image reconstruction and deep learning enhancement strategies that improve pediatric brain imaging by enabling at most 5-fold reduction in Gd injection dosage and 3-fold acceleration of the typical pediatric brain MRI protocol. We aim to develop, validate and translate this imaging technology in clinical settings, thus enabling faster and safer pediatric brain exams with the potential to completely obviate the need for sedation or anesthesia and significantly reduce the dosage of Gd injections given during an MRI exam.